Define the molecular bases for cryptococcal adaptation to host conditions by the RAM pathway

Abstract
Cryptococcal meningoencephalitis is responsible for 15% of the total deaths of AIDS patients. There is
no vaccine available for cryptococcosis and the disease claims hundreds of thousands of lives each year, with
the global mortality rates of ~70% despite current antifungal therapies. The challenges of preventing and
treating this disease motivate the investigation of cryptococcal pathways that are critical for pathogenesis. As
Cryptococcus neoformans is an environmental basidiomycetous yeast, the ability to survive and amplify in
conditions physiologically relevant for the human host is a prerequisite for its pathogenesis. Both high
temperatures (≥37C) and CO2 levels (≥5%) in humans differ considerably from the fungus' primary
environmental niches (CO2 in ambient air is ~0.04%). Accordingly, environmental cryptococcal isolates that are
CO2-sensitive showed drastic virulence attenuation in mouse models of cryptococcosis. The applicant found
that disruption of any of the conserved components of the RAM pathway in the CO2-tolerant clinical isolate
H99, including the effector kinase Cbk1, rendered the strain unable to grow at host temperatures or CO2 levels.
Consistently, the cbk1 mutant is avirulent in both an intranasal infection model and an intravenous infection
model of cryptococcosis. Thus, understanding how the RAM pathway regulates cryptococcal thermotolerance
and CO2 tolerance will inform us about how this fungus adapts to host conditions to cause diseases in humans.
As nothing is known about downstream effectors of the RAM pathway in basidiomycete fungi, the
applicant carried out a pilot suppressor screen of the cryptococcal cbk1 mutant. Analyzing the suppressor
mutants revealed that disruption of either of the two RNA-processing regulators, Ssd1 and Psc1, partially
restored cbk1's thermotolerance and CO2 tolerance. Ssd1 is conserved among fungi and a known target of
Cbk1 based on studies in ascomycetes, including model yeasts or pathogenic Candida species. In the
absence of phosphorylation by Cbk1, Saccharomyces Ssd1 translocates to processing or P-bodies and stress
granules, thereby suppressing translation of its bound mRNAs. By contrast, Psc1 is an uncharacterized protein
with a PARN RNA-recognition motif. The PARN motif is present in many eukaryotic lineages including
basidiomycete fungi and humans, but surprisingly absent in ascomycetes such as Saccharomyces or Candida
species. Based on these observations, the applicant hypothesizes that thermotolerance and CO2 tolerance in
Cryptococcus are regulated by the RAM pathway  at least partly  at the post-transcriptional level. In this
exploratory R21 application, the applicant seeks to (1) define Cbk1 kinase downstream targets in Cryptococcus
by comparative phosphoproteomics and extensive suppressor screens and (2) identify biological processes
controlled by the RAM pathway by defining the proteins and mRNAs bound by Ssd1 and Psc1 in the presence
and absence of Cbk1. These findings will deepen our understanding of how C. neoformans adapts to host
conditions and may reveal candidates that can be exploited for novel targets against this deadly disease.

Public health relevance
The relevance of this research to public health: Systemic cryptococcosis is a serious threat to public health, causing hundreds of thousands of deaths each year. This project is to characterize the RAM pathway that is essential for Cryptococcus adaptation to the host physiological conditions and consequently the ability of this fungus to cause disease. Findings from the proposed research will deepen our understanding of cryptococcal pathogenesis and suggest targets for the potential development of novel therapies to prevent or manage this fatal disease.